Theory and SImulation of Viral Replication

PROJECT SUMMARY
Viruses are infectious agents that replicate inside the living cells of an organism, and it remains critical to
understand the basic molecular mechanisms that govern viral replication, as they perform numerous complex
physical and chemical processes ranging from atomic-scale phenomena, such as the quantum chemistry of
bond cleavage to large-scale processes, such as protein self-assembly. These processes are fundamentally
multiscale since they span time and length scales from the molecular to the mesoscopic. For instance, during
viral particle maturation, proteolytic cleavage of the group-specific antigen polyprotein (Gag) releases capsid
domain proteins (CA) that subsequently reassemble into a fullerene capsid. Our overarching goal is to study
the molecular processes involved in viral replication using theory, physics-based modeling, and computer
simulations.
This proposal focuses on five key aspects of the viral life cycle: (1) how innate immune sensors like the
tripartite motif containing protein 5 α (TRIM5α) restrict viral infection by assembling into hexagonally-patterned
lattices to physically cage the viral core and signal the capsid for degradation, (2) the material and physical
properties of the capsid shell that encases and protects the viral genome, (3) the chemical features of pH-
gated pores distributed throughout the capsid surface, (4) the large-scale morphological changes that occur
during virion maturation, and (5) the conformational dynamics of spike proteins in SARS-CoV-2 virion fusion.
Our strategy is to develop multiscale simulation methods to link molecular behavior at one length-scale to the
next. Coarse-grained (CG) methods and reduced representation models will be developed that retain the
essential physics of the biological process and are also computationally efficient to simulate large-scale viral
processes. All-atom (AA) simulations will be used to accurately probe protein conformational dynamics. Bond
cleavage and formation will be described using mixed quantum-classical approaches, e.g., quantum
mechanical/molecular mechanics (QM/MM) calculations. These simulations will serve as the basis for
developing reactive CG models based on hybrid kinetic Monte Carlo molecular dynamics (MC/MD) to link
quantum phenomena to the CG scale.
Computational predictions on viral replication will be tested and validated in collaboration with leading
structural biologists and biochemists. Collectively, insights from these studies will broadly impact the fields of
molecular simulation, virology, and computational biophysics. Findings from these studies have the potential to
aid in the development of new therapeutic strategies to combat viral infection.

Public health relevance
PROJECT NARRATIVE This project concerns the development and application of multiscale simulation methods to study viral replication in collaboration with experimental structural biologists and biochemists. The specific systems to be studied are implicated in the innate immune response, viral capsid properties, infection of HIV, and SARS- CoV-2 transmission. The findings from this work will advance fundamental knowledge in molecular simulation, virology and biophysics and have the potential to aid in the development of new antiviral strategies.